Rational development of a vaccine against tick-borne rickettsioses

Abstract
Rickettsiae are a group of arthropod-associated, obligately intracellular Gram-negative bacteria that are closely
related but potentially cause life-threatening infection in humans. Tick-borne rickettsioses (TBRs) are
increasingly posing serious threat to the public health in the US due to increased incidence and lack of
commercially available vaccine for prevention. Therefore, a safe and effective vaccine against TBRs will be
an important resource that will ensure the Nation’s capability to prevent this group of diseases. Our long-
term goal is to develop novel approaches for safe and effective immunoprophylaxis of TBRs. Our recently
published and pilot studies demonstrated that live-attenuated R. parkeri mutant 3A2 conferred full protection
against lethal challenge of two highly virulent rickettsiae in mouse models, accompanied by generating high titers
of IgG antibodies reactive against several pathogenic rickettsial species and significantly elevated type 1 T cell
memory immunity. These findings support the proof-of-concept that live-attenuated vaccine candidate serves a
feasible and effective approach to prevent TBRs and study vaccine-induced memory immunity against TBRs.
Thus, the objectives of this R01 application are to generate a safe and efficacious live-attenuated vaccine
(LAV) against TBRs, define the protective efficacy of LAV against homologous and heterologous rickettsial
strains, and mechanistically determine the immune correlates of vaccine-elicited protection against tick
transmission of TBRs. To achieve these objectives, we propose three specific aims to test the central
hypothesis that the LAV will elicit high quality CD8+ T memory cells and rickettsiae-specific neutralizing
antibodies to confer complete protection against natural acquisition of TBRs as a safe and efficacious polyvalent
vaccine candidate. Aim 1 will optimize R. parkeri mutants genetically to reduce virulence, enhance safety while
maintaining immunogenicity. Aim 2 will define the efficacy of genetically optimized R. parkeri mutants in
protecting against TBRs in both needle-challenge and tick transmission animal models. Aim 3 will identify the
immunological correlates of vaccine-induced protection against TBRs. Upon the completion of the proposed
research, we expect to define the first multivalent vaccine candidate for TBR and reveal the novel elements of
host immunity responsible for prevention from natural transmission of TBRs. This will have significant positive
effects on human health because it will provide the basic information required to ultimately develop a safe,
effective, and tractable vaccine against TBRs.

Public health relevance
Project Narrative Spotted fever rickettsioses are potentially life-threatening diseases. Since no licensed vaccine is available, we aim to develop vaccine candidates and investigate how a vaccine protects spotted fever rickettsioses using animal models. This research will to help us to prevent these tick-transmitted diseases.